Meaningful data integration, visualization and distribution for Human Pain Associated Genes & Cells Datasets

Project Summary:
The PRECISION Human Pain project has a primary goal to develop a comprehensive datasets of molecular
signature cell types, and cellular function phenotypes or signatures that underlie human pain signal
transduction, transmission, and processing. To maximize the impact of the data generated through this effort, it
is vital to standardize and integrate all data generated by the U19 centers and make these data available in a
meaningful way to the larger scientific community. As the data coordination and integration center, we will
support the PRECISION Heal initiative to generate a high impact resource for sharing, visualizing datasets, and
making these datasets actionable for downstream analysis and scientific investigations. Over the last 7 years,
our interdisciplinary team has developed platform technologies, standards, and visualization mechanisms to
look at physiological data in context for several NIH programs (e.g. SPARC and REJOIN). Our combined domain
expertise spans the requirements to facilitate complex data integration specifically for Neuroscience and
physiology datasets. We will leverage our existing platform technologies and workflows to rapidly engage with
the HEAL PRECISION U19 centers and lead the effort to develop the knowledge and data integration
capabilities needed to support high impact research.
We will expand our workflows to be tightly integrated with the existing HEAL Data Ecosystem, its
repositories, and any workflow and data integration requirements by the individual U19 data cores. In this
proposal our goals are: (1) To develop a data management and knowledge platform for HEAL Precision
centers to standardize datasets across the HEAL Precision U19 data collection centers, provide the means to
share data amongst the consortium in a meaningful way prior to data publication and integrate knowledge
across all submitted data (2) To develop novel visualization and data exploration mechanisms to interact with
these data in context as part of an integrated data ecosystem. (3) To increase the impact of the HEAL
PRECISION program through operational support, outreach and educational efforts. This project leverages an
established inter institutional collaboration between investigators across BioInformatics, Physiology and
Knowledge Management with a track record of successfully supporting large NIH efforts with data resource
management.

Public health relevance
Project Narrative: Meaningful collaborative research requires a systematic approach to data collection, curation, and distribution. The goal of this effort is to develop a rich, meaningful resource for knowledge transfer between researchers to accelerate research and our understanding of Human Pain which requires integration of generated data and metadata and accompanying mechanisms to visualize, query and interact with these data resources. Our interdisciplinary team will develop workflows, tools, and infrastructure to integrate and share Human Pain Associated Genes and Cell Datasets with the larger scientific community and build a knowledge platform to visualize, query and interact with these data in a meaningful way.